Synaptic mechanisms of functional recovery after stroke

Remapping of function after stroke relies on the rewiring of cortical circuitry. These structural
modifications of circuits likely depend on nanoscale alteration in the molecular architecture of individual
synapses that generate alternate connectivity and strengthen surviving contacts. NMDA- and AMPA-type
glutamate receptors play critical roles in regulating structural and functional plasticity of synapses.
Following a stroke, the signaling via AMPARsand NMDARs changes, likely due to changes in their
nanoscale localization. The small size of synapses has prevented us from understanding how synaptic
nano-architecture is altered by stroke and how nanoscale synaptic changes might lead to functional
recovery, limiting our ability to target synapses for stroke intervention. Our proposal seeks to break down
this barrier by combining state-of-the-art STEDsuper-resolution imaging with behavioral analyses of
sensorimotor function in the mouse model of stroke. Our preliminary data indicate that AMPARsand
NMDARs exhibit distinct organizational principles relative to spine size and presynaptic release sites,
suggesting that the exact set of nanoscale rules governs synaptic transmission and plasticity. We will
test the hypothesis that precise nanoscale remodeling of individual spine synapses underlies the
functional recovery after stroke. In aim 1, we will determine how changes in pre- and post-synaptic
nano-architecture on cortical pyramidal neurons are linked to functional recovery after stroke. By imaging
the organization of scaffolding (PSD-95 and Bassoon) and functional (AMPARs, NMDARs, Munc-13)
components of synapses in early and late phases of recovery after stroke, we will establish how changes
in synaptic nano-architecture relate to the recovery of sensorimotor function in both young and old mice.
In aim 2, we will determine the role of ephrin-B3 on the remodeling of spine nano-architecture on cortical
pyramidal neurons during stroke recovery. Testing ephrin-B3 null mice in sensorimotor behavioral
paradigms, we will determine whether ephrin-B3 is required for the functional recovery after stroke.
Finally, using two-photon and STEDimaging of dendritic spines in the somatosensory cortex, we will
determine whether ephrin-B3 regulates synaptic remodeling after stroke. Novel molecular insights
gained from this research will improve our understanding of stroke pathology while providing
mechanistic underpinnings into functional recovery.

Public health relevance
The mechanisms that link structural changes in the brain connectivity to the remapping of function after stroke are unknown. Here we will define how synapses are impacted by stroke and determine the synaptic mechanisms that underly the recovery of lost function in the mouse model of stroke. The results of this work will provide mechanistic underpinnings of functional recovery after stroke and have the potential to identify novel therapeutic targets that will lead to improvements of function in stroke patients.